AR² - Autism Replication, Validation, and Reproducibility Center

Abstract
Autism Spectrum Disorder (ASD) research, particularly in light of its increasing prevalence and societal
impact, requires rigorous replication and validation (R&V) to ensure that scientific findings are reproducible,
generalizable, and applicable across diverse populations and settings. We propose an independent Autism
Replication, Validation, and Reproducibility (AR²) Center in response to the NIH Autism Data Science
Initiative (ADSI) Task IV, “Model Validation or Method Replication”. The primary goal of AR² is to ensure
that every ADSI-generated resource is paired with an AR²-certified, complete, standalone package—fully
aligned with FAIR (Findable, Accessible, Interoperable, and Reusable) principles—that enables
independent reproduction of data generation, aggregation, or modeling processes in external environments
and supports transparent, verifiable downstream analyses by the broader autism research community.
AR² builds upon the nationally recognized Cornell Center for Social Sciences (CCSS) Data and
Reproduction Archive, a CoreTrustSeal-certified infrastructure with a data archive and results replication
(R2) pipeline that has archived over 2,150 studies and replicated more than 130 published datasets since
1982. Expanding on this proven infrastructure, AR² will establish a standardized, co-ownership pipeline with
ADSI teams to collaboratively define R&V scope, success criteria, and deliverables; execute internal and
external validation where applicable; and deliver certified R&V packages, including annotated code, test
datasets, metrics, and compliance documentation (Aim 1). AR² will draw upon large-scale, racially, and
geographically diverse autism-relevant data sources—including the INSIGHT Clinical Research Network,
PEDSnet, PCORnet, Inovalon, and Medicaid claims datasets—to support robust validation and
generalizability evaluation. Throughout the ADSI funding period, AR² will promote R&V best practices
across the autism research community through targeted training and workshops and will coordinate closely
with ADSI program staff, project teams, and a Community Advisory Board to ensure alignment with evolving
scientific and community priorities. Final deliverables will be disseminated through accessible, trusted
repositories to maximize transparency and impact (Aim 2).
By applying standardized, FAIR-aligned workflows, leveraging a nationally recognized R&V infrastructure,
and utilizing diverse datasets spanning racial/ethnic, geographic, and socioeconomic groups, AR² will
rigorously replicate, validate, and document the generalizability of individual ADSI projects. Through these
efforts, AR² will foster a culture of open, reproducible autism research and accelerate the translation of
autism data science into clinical practice and policy.